HIV Center for Clinical and Behavioral Studies

Even in the face of new public health and political crises, the HIV/AIDS epidemic remains a critical public
health emergency. Health disparities and structural inequities are still significant drivers of the U.S.and global
epidemic, with the most vulnerable and marginalized hardest hit. This competitive renewal of the HIV Center for
Clinical and Behavioral Studies (HIV Center) at New York State Psychiatric Institute (NYSPI) and Columbia
University (CU) is based on the premise that biomedical advances for HIV prevention and treatment will not
reach their full potential without rigorous behavioral, social science, and translational research to optimize
uptake, adherence, and equitable implementation and scale-up. We will build on our interdisciplinary HIV
research history– leveraging emerging knowledge bases and new and continuing community, scientific, and
health department partnerships to actualize the power of biomedical advances in HIV prevention and care for
the most vulnerable populations. Our Center evolves with each renewal – refocusing and bringing in new
collaborators to meet current HIV/AIDS scientific and public health challenges. In the next five years, guided by
the theme, Reducing HIV and Mental Health Disparities to End the HIV Epidemic (EHE), we will bring
together an expanding group of investigators and clinical and community partners working at the forefront of HIV
behavioral, social, biomedical, and implementation sciences. The renewed HIV Center will provide a rigorous,
theoretically grounded behavioral and social science foundation that catalyzes and supports robust, innovative
HIV research to maximize the benefit of biomedical advances for vulnerable US and global populations by
addressing the following three Specific Aims: (1) To advance our understanding of individual, social, and
systemic drivers of the HIV epidemic including mental health and social determinants of health and
development of intervention and implementation science research to achieve local, national, and global EHE
goals; (2) To promote translation of clinical and research findings to prevention and care settings for
maximum equitable public health impact; and (3) To expand the cadre of HIV researchers by engaging an
inclusive pipeline of emerging investigators – particularly those from groups under-represented in research. Our
Cores ensure methodological and theoretical rigor, rapidly respond to new trends in the epidemic, support critical
research-practice partnerships, and train new scientists. Three Research Cores will complement the
Administrative and Development Cores: (1) Statistics, Data Science, and Data Management Core, promoting
state-of-the-art approaches to study design, data science, and data analytic methods; (2) Clinical Translation
Core, integrating biomedical and behavioral research for implementation in real-world settings; and (3) Health
Equity Core, focusing on HIV disparities mediated by mental health problems including substance misuse and
social determinants of health.

Public health relevance
The HIV Center will advance the goals of the US National HIV/AIDS Strategy, the NIH, and UNAIDS to End the HIV/AIDS Epidemic (EHE), by stimulating and supporting research that targets the US and global communities most affected by racial, social, and health disparities; mental health challenges; and health inequities. We will build and expand on our history of interdisciplinary HIV research – leveraging emerging knowledge bases and new and continuing community, scientific, and health department partnerships --to promote research focusing on individual, social, and systemic barriers to actualizing the power of biomedical advances in HIV prevention and care for the most vulnerable. We will identify and rapidly respond to new trends in viral epidemics supporting research-practice partnerships that foster innovation, train the next generation of scientific leaders, including those from under-represented groups, increase understanding of drivers of the epidemic, and foster translation of clinical and research findings to prevention and care settings for maximum equitable public health impact.